Amyloid-Beta and Tau/Glycosaminoglycan Dual Inhibitor for Alzheimer's Disease

ABSTRACT
The aim of this project is to support an IND application for GTC-3295 for the treatment of
Alzheimer's Disease (AD). Neurodegenerative amyloid diseases such as AD have common
underlying biochemical pathways leading to oligomerization and aggregation of amyloidogenic
peptides and prion-like spreading of amyloid proteopathic seeds throughout the Central Nervous
System (CNS). Recent data suggest that heparan sulfate glycosaminoglycans (HS-GAGs) are
the receptors responsible for internalization and spreading of amyloid-beta (Abeta) and tau
neuropathologies in the brain. We are developing a novel class of therapeutics,
Glycosaminoglycan-Interacting Small Molecules (GISMOs), for the treatment of AD. GISMOs
are drug-like small molecule compounds that inhibit Abeta and tau interactions with HS-GAGs,
each of which is a key molecule implicated in AD pathogenesis, and may reduce propagation of
these aggregated proteins in the Alzheimer's brain. GTC-3295 is a New Chemical Entity (NCE)
and has dual activity as it efficiently inhibits both Abeta as well as Tau interactions with HS-
GAGs. In previous studies in a transgenic mouse model of AD, GTC-3295 decreased amyloid
burden in the mouse brain by as much as five-fold, and significantly decreased
hyperphosphorylated tau levels in CA1 region of hippocampus. Initial preclinical studies indicate
that GTC-3295 is an orally available and brain penetrant compound possessing favorable
properties in in vitro ADME, pharmacokinetics, toxicity and other studies. These results provide
justification to continue developing GTC-3295. In this SBIR project, we will perform a number of
IND-enabling preclinical studies including GLP Toxicology studies in two species, scale-up
synthesis, formulation studies, and development of bioanalytical methods. We will also evaluate
efficacy of GTC-3295 in two transgenic models of AD, that separately address Abeta and tau
neuropathologies. Completion of these requisite development activities should position this
project towards a successful IND submission to the FDA and advancing into Phase I clinical
trials in humans.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease is a progressive neurologic disease of the brain leading to the irreversible loss of memory and cognitive performance which become severe enough to impede social or occupational functioning. This chronic, debilitating disorder results in a devastating burden on the families and caregivers of patients, with the rising costs of care in the United States exceeding $170 billion a year. The goal of this SBIR proposal is to develop a novel and orally effective small molecule for the treatment of Alzheimer’s disease. The drugs described in this proposal act via a novel and highly differentiated mechanism of action and are postulated to exhibit an improved efficacy / safety risk compared to the current standard of care.